Using Exercise to Enhance Consolidation of Exposure-Based Therapeutic Learning in PTSD

Project Summary
The proposed R61/R33 project would build on our published pilot data and animal models to demonstrate that
moderate intensity physical exercise delivered after exposure therapy engages fear circuitry and enhances the
consolidation of therapeutic safety learning, thereby enabling enhanced symptom reduction for PTSD. In the
R61 target engagement phase, adults with PTSD related to interpersonal violence (IPV) exposure would
complete an initial session of imaginal exposure to traumatic memory cues adapted for an MRI setting. This
would be followed by 30-mins of moderate intensity exercise or low intensity walking control. Participants
would return 24-hrs later to complete a second session of imaginal exposure with MRI. We hypothesize greater
between-session reductions in fear responding and fear circuit activation to traumatic memory cues 24-hrs
later among those who exercised following the first session compared to those in the walking control condition.
The R33 phase will build upon successful target engagement and adapt a brief version of prolonged exposure
(PE) therapy to include moderate-intensity exercise or walking control after imaginal exposure. We hypothesize
that PE with exercise will result in more rapid and larger reductions in PTSD symptoms and reduced fear-
related neurocircuitry activation and affective arousal to trauma cues compared to PE plus walking control.
Overall, this project is designed to demonstrate that a novel intervention (moderate intensity exercise) engages
key mechanisms of therapeutic exposure, thereby enhancing the efficacy of exposure therapy.

Public health relevance
Project Narrative The proposed project would explore the viability of moderate intensity exercise, delivered following exposure therapy, as a novel means of enhancing consolidation of therapeutic safety learning and exposure therapies. This knowledge has the potential to increase therapy outcomes for patients with PTSD and related disorders.